Precision Interception of Aggressive Prostate Cancer in African American Men

Summary The Biospecimen and Biomarker Core (BBC) provides key functions for biosample collection, processing, evaluation, storage, and biomarker generation to all three P20 projects and the DRPs. The BBC will provide multiple pathology services, including detailed histopathologic review of tissues; characterization of normal and tumor tissue; characterizing inflammatory infiltrate; identifying early lesions and prostatic intraepithelial neoplasia (PIN); annotating well-characterized frozen and paraffin tissue samples in the tissue bank; and providing sections and samples of tissues for project investigators. The BBC will provide state of the art imaging services and quantitation of nucleic acids and proteins. The BBC will generate a clinically-linked archival paraffin tissue series of human prostate cancer, including construction of a tissue microarrays (TMA), immunohistochemistry (IHC), tissue coring for nucleic acid analysis, and image analysis of biomarkers. We will further provide a variety of services critical to successful molecular analysis of mouse and human prostatic tumors including: histopathologic review and quality control analysis of all tumor samples utilized in experimental studies; slide macrodissection of paraffin-embedded tissues to ensure high neoplastic cellularity for samples utilized in experimental studies; laser capture microdissection (LCM) to provide ultra-pure tumor samples and microscopic sub-populations of cells (such as immune cell populations); optimization of techniques in nucleic acid extraction tailored to the experimental goals of the P20 investigators; performance and analysis of routine and highly multiplexed IHC and immunofluorescence (IF) stains on TMAs of human prostate adenocarcinomas; optimization and validation of antibodies to known and novel proteins for use in human IHC; performance and analysis of a broad range of IHC stains in human tissues in direct support of the projects. The BBC will also provide resources and technologies for molecular characterization that are required for the projects’ research activities. The BBC will adapt and implement new resources and technologies to meet the scientific goals of the projects. We provide platforms for high throughput IHC and IF with sophisticated image analysis instrumentation and tools. We will also provide genomics services including the use of targeted cancer panels (e.g., Oncopanel), RNASeq, Nanostring, Affymetrix arrays, and other related tools as required by the projects. Finally, the BBC will manage tissue banking, molecular output, and clinical data for translational research. The BBC will manage the central data repository for tissue and biosample banking, as well as integration with the clinical data resource for the projects. The BBC is essential to the success of all Projects via the provision of annotated and highly characterized specimens, the performance of molecular-based techniques on experimental tissue specimens and the development of novel, sophisticated and high-throughput molecular pathology tools to improve efficiency and accuracy of pathologic evaluations.

Public health relevance
Core B NARRATIVE The Biosample and Biomarker Core will provide services for research biosample collection and processing as well as molecular typing for all three of the projects in this P20 grant.